Understanding the immunometabolic mechanism of VGLL3 mediating female-biased autoimmunity

ABSTRACT
Autoimmune diseases exhibit strikingly increased prevalence in females (e.g. systemic lupus erythematosus
[SLE], female-to-male ratio 9:1), whereas in contrast, infectious diseases affect more men than women.
Despite its clinical impact, the molecular underpinnings of sex-biased immune regulation remain elusive. To
address this knowledge gap, this project focuses on the immunometabolic function of VGLL3 (Vestigial Like
Family Member 3), a female-increased, keratinocyte-expressed molecule known to promote both cutaneous and
systemic autoimmunity. This project tests the hypothesis that VGLL3 coordinates female-biased metabolic
stress response, whose hyperactivation causes autoimmunity by:
Aim 1. Define the female-biased cellular stress response mediated by VGLL3.
Aim 2. Determine the molecular mechanism by which metabolic stress potentiates VGLL3 induction by
IFNα.
Aim 3. Establish the in vivo role of VGLL3-mediated stress response in autoimmune pathogenesis.
With successful completion of the work proposed, we will have gained insights into the molecular basis
underlying sexual dimorphism in immunity. By establishing the immunometabolic function of VGLL3, we will
demonstrate the importance of maintaining metabolic homeostasis in combating autoimmunity, and provide a
novel target and pathway for sex-specific prevention and treatment of immune-associated diseases.

Public health relevance
PROJECT NARRATIVE This project aims to establish the VGLL3-mediated, immunometabolic mechanism underlying female-biased autoimmunity. It has the potential to provide novel, pharmacologically targetable pathways for the prevention and treatment of autoimmune diseases, and guide personalized treatment of immunological diseases in order to address the sex-specific effects of drugs.